Stem cell- based studies of gene-environment interactions in PTEN- associated autism

While autism spectrum disorders (ASD) are highly heritable, it is clear that there is also a strong environmental component to ASD pathogenesis. ASD is frequently associated with brain enlargement, which is often present at birth and affects multiple cell types, suggesting that dysfunction in an early stem or progenitor population contributes to ASD etiology. We hypothesize that brain enlargement is related to enhanced self-renewal of neural stem cells (NSCs) leading in turn to increased neurogenesis and abnormal connectivity that has been observed in ASD. Mutations in the tumor suppressor PTEN that are observed in association with the autism macrocephaly phenotype are almost all heterozygous (HET), although HET mutations in mice produce few or subtle brain abnormalities. PTEN HET mutations in humans may or may not contribute to autism with brain overgrowth on their own but could act as a genetic susceptibility in combination with environmental factors that affect their function. One known environmental risk factor for ASD that might interact with genetic risk factors is the Maternal Inflammatory Response (MIR). Although MIR has been linked to both autism and to brain overgrowth, the biologic mechanisms for its potential pathological effects remain undefined. We will test the hypothesis that reactive oxygen species (ROS) generated by MIR exposure can increase stem cell self- renewal and neurogenesis in human neural stem cells through the reversible oxidative inactivation of PTEN protein and subsequent enhancement of PI3K pathway activation and that this effect is enhanced by heterozygous PTEN mutation. To do this we will use state of the art methods to generate lymphocyte-derived induced pluripotent stem cells (iPSCs) from our unique clinical population with identified PTEN HET mutations, brain overgrowth, and autism and from unaffected relatives. We will then derive forebrain NSCs from the iPSCs to test the hypothesis that PTEN mutations interact with ROS to promote an abnormal degree of self- renewing proliferation and neurogenesis. This will be done by directly exposing cells to ROS as well as to candidate inflammatory cytokines that are known to be produced by MIR, and, which, in turn could activate ROS production. We will determine the molecular mechanisms underlying the altered cellular phenotypes that we may observe through the analysis of the PI3K and other pathways that may interact with the PI3K pathway. We will also determine whether different forms of PTEN HET mutations which may result in different levels of residual PTEN function respond differently to ROS/cytokine stimulation. These studies will elucidate the relationship between genetic susceptibility and exposure to MIR that could inform the development of novel interventions by identifying mechanisms of susceptibility to a common environmental risk factor. The findings obtained in this study will also have broader implications for susceptibility to environmental autism risk factors due to the fact that there are many different genetic susceptibilities that may interact with MIR through final common pathways which lead to altered neural stem cell function during critical periods in brain development. .

Public health relevance
Project Narrative Gene mutations can interact with environmental influences to cause autism. We have developed a novel theory that these gene-environment interactions may act on stem cells in the brain, resulting in an overproduction of cells in the brain and the development of autism symptoms. We will make induced pluripotent stem cells from autistic individuals with large brains and mutations in the PTEN gene to investigate the interaction of this genetic susceptibility with the effects of maternal inflammation (MIR), a known environmental risk factor. We will determine the cellular and molecular mechanisms that underlie neural stem cell dysfunction and brain overgrowth following MIR exposure, which could, in turn, identify novel therapeutic targets.